Neuroimmune and Cognitive Consequences of Nicotine Use in a Rodent Model of HIV: Implications for Anti-Retroviral Therapies

PROJECT SUMMARY/ABSTRACT
This A-START R03 will examine the role of volitional nicotine use in exacerbating neuroimmune consequences
of HIV using a rat model in support of a larger R01. Clinically, persons living with HIV (PLWH) are 2-3 times more
likely than the average population to use nicotine-containing products and are less likely to quit. Further,
combined anti-retroviral therapy (cART) does not reverse neurocognitive impairments induced by HIV infection,
and PLWH often present with comorbid anxiety and depression, which smoking is used as a coping strategy.
Despite these clinical associations, the mechanisms underlying these relationships have not been thoroughly
examined using preclinical models, which can provide sensitive assessments of these relationships. We have
found that chronic nicotine self-administration (SA) is associated with neurobiological adaptations within the
neuroimmune system of the nucleus accumbens core (NAcore) region of the addiction/reward pathway. The
prefrontal cortex (PFC) and amygdala, additional regions within the reward pathway, play a role in preclinical
models of drug use, cognition, and anxiety and thus may critically contribute to nicotine/HIV interactions. Our
preliminary data show that NAcore cytokine profiles are suppressed by nicotine SA, and microglia are sex-
specifically impacted by nicotine use whereby females show heightened vulnerability. Conversely, we show that
blood serum pro-inflammatory cytokines are increased following nicotine SA in females. We further show that
nicotine seeking is critically regulated by NAcore microglia, indicating that these neuroimmune cells may have
outsized control over nicotine-motivated behavior. Together, these immune consequences of nicotine use may
have implications for PWH because HIV is characterized by profound inflammation. We hypothesize that
chronic volitional nicotine SA improves HIV-associated neurocognitive disorders (HAND) and anxiety, but
exacerbates HIV-induced neuroimmune signaling, leading to greater use motivation. Here we will utilize the
EcoHIV viral construct during nicotine SA to recapitulate microglial infection, as well as neurocognitive
impairments and anxiety-like behavior seen in the clinical condition. We will evaluate if chronic nicotine SA
enhances cognitive functioning as measured via delayed matching to sample (DMTS), a memory task, and
anxiety-like behaviors in open field testing (Aim 1), and if this is associated with enhanced NAcore, PFC, and
amygdala microglial reactivity both in EcoHIV-infected and non-infected microglia (Aim 2). We will further test if
nicotine and EcoHIV interact to further dysregulate NAcore, PFC, amygdala, and blood serum cytokine profiles
(Aim 2). Importantly, we will test the ability of cART treatment to impact these neurobehavioral endpoints. These
studies will define how nicotine-induced changes in neuroimmune signaling are impacted by EcoHIV infection,
a better understanding of how nicotine’s volitional exposure may influence cognitive performance and anxiety-
like behavior, and how ART may impact these effects which will lead to a larger R01 to fully examine sex-specific
novel neurobiological mechanisms of immune system dyshomeostasis after EcoHIV infection and nicotine use.

Public health relevance
PROJECT NARRATIVE Persons living with HIV (PLWH) are 2-3 times more likely than the average population to use nicotine- containing products, and although nicotine use may improve HIV-associated neurocognitive disorders (HAND), it may also exacerbate neurobiological sequelae induced by HIV infection such as neuroinflammation despite use of anti-retroviral therapies (ART). The proposed research has the potential to uncover novel neurobiological mechanisms by which nicotine use alleviates some of the cognitive dysfunction associated with HIV infection but exacerbates neuroimmune dysregulations utilizing the EcoHIV virus in a rat model of nicotine use.